Deciphering the underlying structure of the glucocorticoid gene regulatory network

ABSTRACT
Gene regulatory networks (GRNs) consist of transcription factor (TF) proteins, their associated cis-regulatory
elements (CREs) and target genes. These networks function as the central information processing hub within
cells, orchestrating precise spatiotemporal control of gene expression in response to environmental signals,
including medications. Glucocorticoids (GCs), commonly known as steroids, are among the most prescribed
medications, proving highly effective in treating various conditions, from autoimmune diseases and inflammation
to cancer. In B-cell acute lymphoblastic leukemia (B-ALL), GCs are a mainstay of contemporary multi-drug
chemotherapy, and GC drug resistance is predictive of relapse and poor clinical outcome. We have mapped
CREs that are crucial for the glucocorticoid gene regulatory network (GC-GRN), referred to as GC-response
CREs (GCREs), by integrating diverse epigenomic, transcriptomic and high-throughput functional assays. Our
previous work indicates that GCRE disruptions contribute to GC drug resistance in primary cells from patients
through decreased cell apoptosis. Building upon our previous findings, we hypothesize that genetic alterations
to GCREs impact gene regulatory responses to GCs, and they are therefore important contributors to GC drug
resistance and clinical outcome in B-ALL patients. However, our knowledge on how GCREs are encoded in the
human genome remains incomplete. Moreover, our comprehension of GCRE function and the impact of genetic
variants within GCREs is still rudimental. To bridge this knowledge gap, we propose to: (a) utilize our extensive
chromatin accessibility data that identified CREs in primary B-ALL cell from patients to expand our initial GCRE
mapping in a diverse panel of human B-ALL cell lines, (b) identify the specific GCREs that impact GC drug
resistance, (c) elucidate DNA sequence variants that modulate gene regulatory responses to GCs and (d)
evaluate the consequences of GCRE disruptions identified in primary B-ALL cells from patients on GC drug
resistance. Our long-term goal is to utilize the GC-GRN as a model for quantitatively assessing and modeling
the functional effects of noncoding genetic variations on healthy traits and human disease. Collectively, these
results will lead to a better understanding of how GRNs are encoded in human genomes, and how alterations to
GRNs contribute to cellular phenotypes, complex traits and human disease.

Public health relevance
PROJECT NARRATIVE Although gene regulatory networks (GRNs) govern genome function and underlie diverse physiological and developmental processes, our overall understanding of how these networks are encoded in DNA sequences and how genetic alterations to these networks impact cellular function, complex traits or disease is still rudimentary. Our proposal utilizes glucocorticoid signaling in B-cell acute lymphoblastic leukemia (B-ALL) cells as a model for quantitatively assessing and modeling the functional effects of noncoding genetic variation. As a result, this approach will uncover cis-regulatory elements and DNA sequence variants that contribute to cellular glucocorticoid drug resistance and other pharmacogenomic traits in B-ALL patients.